Rational design and testing of blood-brain-barrier shuttle peptide

PROJECT SUMMARY
Therapeutics targeting the central nervous system (CNS) have a less than 10% likelihood of approval through
the entire clinical trial process. This very low approval rating is a significant problem for both pharmaceutical
companies (lost investment) and patients (fewer advanced treatment options), and it has often been tied to the
difficulty of penetrating the blood-brain-barrier (BBB). It is generally reported that 98% of small molecules and all
macromolecules and proteins are prevented from crossing the BBB. As a result, several key strategies have
been developed in order to increase the likelihood of CNS entry. These range from chemical modification to
increase lipophilicity (e.g. esterification), modulating the physical properties of the BBB, and to mimicking or
conjugating to non-specific transporter substrates (e.g. nutrients such as sugars or amino acids). While these
methods have shown promise in some cases, they all have significant drawbacks including a potential loss of
activity, significant or severe side effects, and a lack of BBB targeting specificity resulting in possible systemic
side effects, respectively. A fourth and more specific approach has therefore been developed, in which specific
receptors on the BBB are targeted. One notable example has been the use of the transferrin receptor (TfR),
which is responsible for iron uptake and transport. Conjugation of drugs such as chemotherapeutics to TfR
targeting agents has been demonstrated to significantly increase CNS uptake and tumor targeting. However,
targeting TfR, can also result in significant off-target localization and toxicity as it has been found with other
widely distributed receptors (e.g. insulin receptor).
We have therefore devised a new modification strategy by which large macromolecules and proteins may
be modified to target the α7 subunit of the nicotinic acetylcholine receptor (α7nAChR) in order to efficiently cross
the BBB. Our preliminary data demonstrates that through our modification strategy, we could successfully alter
enhanced green fluorescent protein (eGFP) without affecting its fluorescent properties and without degrading its
stability. Furthermore, this fluorescent acetylcholine receptor binding eGFP (FARB, Swiss German for color)
localizes in primary neuronal cells through α7nAChR, is non-toxic, and localizes in mice brains (preliminary data).
In this project, we therefore seek to confirm the efficiency of our FARB protein in crossing the BBB in vivo
with both wild-type and α7nAChR knockout mice. This will be accomplished by tracking the distribution and
fluorescent signals from both FARB and eGFP over time with an IVIS imaging system and then quantifying the
concentration of both proteins in major organs (brain, heart, lungs, etc.), blood, and urine at various time points.
Finally, immunohistochemical analysis of brain slices will allow us to determine the brain region(s) that are most
targeted by FARB. Completing this project will demonstrate a new modification strategy that may be used to
significantly increase the efficiency with which the CNS can be targeted by macromolecules and/or proteins.

Public health relevance
PROJECT NARRATIVE The blood-brain barrier blocks nearly 98% of small molecules and nearly all macromolecules and proteins, preventing the entry of most therapeutics that are designed to target and treat neurological, psychiatric, or other central nervous system disorders. Here, we will further investigate our newly designed peptide conjugation strategy that can be used to deliver macromolecules and proteins efficiently across the BBB, as demonstrated in our preliminary data. This project will characterize the distribution and excretion of our modified proof-of- principle fluorescent protein following its administration to wild-type and target-protein knockout mice to further demonstrate the safety and efficiency of our method.